Cellular crosstalk and molecular mechanisms in the initiation and progression of pulmonary fibrosis

SUMMARY
Recurrent alveolar injury and dysregulated signaling in alveolar cell niche have been implicated in the
pathogenesis of pulmonary fibrosis. While genome-wide association studies further supported this model, the
precise cellular triggers and the molecular mechanisms that drive alveolar fibroblasts replication and their
conversion into excessive extracellular matrix producing myofibroblasts remain elusive. Currently we lack a
comprehensive understanding of the cell intrinsic and extrinsic homeostatic mechanisms that normally control
fibroblasts replication and prevent their conversion into pathological myofibroblasts.
Our recent finding that either conditional ablation of alveolar epithelial type-1 (AT1) cells, or loss of Pdgfra
specifically in PDGFRA-expressing fibroblasts (alveolar fibroblasts) in vivo, results in spontaneous conversion
of alveolar fibroblasts into myofibroblasts and fibrosis. Single cell transcriptome guided ligand-receptor pair
predictions coupled with alveolar fibroblast cultures in serum-free conditions suggest that AT1 cell-derived
PDGFA is required in proper amounts to both maintain alveolar fibroblasts identity (i.e., prevent their conversion
to myofibroblasts) and control replication. Exploring downstream mechanisms, we have uncovered an increase
in the expression of the transcription factor RUNX1 in both replicating alveolar fibroblasts as well as TGFβ-
induced myofibrogenesis both in vivo and ex vivo. Significantly, our preliminary data also indicate that genetic
loss of Runx1 abrogates PDGFA or TGFβ-induced alveolar fibroblasts proliferation or conversion into
myofibroblasts, respectively. These preliminary data lead us to hypothesize that AT1 cells maintain alveolar
fibroblasts identity via PDGFA – PDGFRA signaling axis and that a fine balance in the amount of PDGFA
is essential for fibroblast quiescence and replication at homeostasis and injury repair. We also
hypothesize that RUNX1 is an essential regulator of both PDGFRA and TGFβ signaling to regulate
replication and myofibrogenic programs in alveolar fibroblasts during regeneration and fibrosis.
The major objectives of this proposal are to define the communication between AT1 cells and alveolar
fibroblasts and to study transcriptional control of myofibrogenesis. In Aim1, we will test the hypothesis that
PDGFA-PDGFRA signaling between AT1 cells and alveolar fibroblasts is essential for alveolar homeostasis. In
Aim2, we will determine context specific functions of RUNX1 in alveolar fibroblasts replication and
myofibrogenesis. We will use novel in vivo genetic mouse models and pharmacological loss-of-function models,
human lung fibroblasts and precision cut lung slice cultures, and molecular assays to study these specific aims.
Our prior expertise in lung regeneration and transcriptional control of cell fates will aid us in studying the proposed
aims. The outcomes from the proposed studies will have broader impact on lung regenerative medicine and will
form the basis for development of therapeutics to prevent and reverse human lung fibrosis.

Public health relevance
PROJECT NARRATIVE Pulmonary Fibrosis is a fatal interstitial lung disease with a median survival of 3-5 years, accounting for ~45,000 deaths/ year in the United States. Currently there are no effective therapies and lung transplantation remains the only option to improve lung function and improve quality of life and survival. Understanding the mechanisms that initiate and promote fibrosis will aid in developing novel therapeutics to block or reverse this disease.